Bioinformatics Shared Resource

BIOINFORMATICS SHARED RESOURCE: ABSTRACT
The Bioinformatics Shared Resource (BISR) provides comprehensive support to MCCCC members in study
design, computational analysis, and other bioinformatics and computational biology activities. The support
includes expert scientific consultation tailored to individual research needs, advanced multiomics analysis for
processing and interpreting high-dimensional data, spatial analysis for both transcriptomic and proteomic
datasets, machine learning, informatics support (in conjunction with the developing Data Science and Artificial
Intelligence resource), and big data analysis methods. BISR also engages the MCCCC Cancer Individualized
Precision Medicine Office to support the 2030 MCCCC vision to bring precision medicine to all cancer patients.
BISR members demonstrate innovation and creativity in applying bioinformatics and computational biology
techniques to MCCCC projects. Recently, Karla Ballman (ACTS, MCR) was named as the new BISR Director,
with Yan Asmann (CII, MCF) named as the Co-director, alongside several other leaders. Ballman also serves
as the Director of the Biostatistics Shared Resource (BSR), reflecting the strong coordination and integration of
quantitative support for the MCCCC. Specifically, closer integration of the BISR and BSR teams will lead to more
cost-efficient and effective collaborations with MCCCC members.
BISR experts support MCCCC investigators through three Specific Aims:
Aim 1: Collaborate with MCCCC investigators, contributing expertise in study design, analysis, interpretation of
results, and dissemination of findings.
Aim 2: Implement, adapt, and develop bioinformatics and computational biology methods and novel workflows
to meet the emerging needs of MCCCC investigators.
Aim 3: Provide bioinformatics educational opportunities for MCCCC members and their trainees.
BISR members are experts in scientific, technical, and operational fields, providing standard and custom analysis
pipelines for various projects. They create robust information management systems and custom application
programming to address unique research challenges. These services streamline data processing and analysis,
facilitate efficient organization and management of research data, and equip researchers with the tools to tackle
complex problems. The BISR provides a wide range of existing services and has the capability to expand to
accommodate new technologies, supporting the diverse needs of MCCCC researchers.
Member Utilization 2019-2023: 212 Total (16 CPCS, 25 REDI, 36 CGSM, 36 CII, 35 NTTM, 64 ACTS)
Publication by Members: 224 total, 41 with Impact Factor >10